DP24-004, PRC, Core: Health Promotion and Disease Prevention Research Centers

PROJECT SUMMARY
Maternal mortality rates are increasing in the United States and hypertensive disorders of pregnancy are a
leading cause of maternal death. Women with hypertensive disorders of pregnancy have increased risk of
adverse fetal and maternal outcomes, developing chronic hypertension, and developing earlier onset of
cardiometabolic risk factors and cardiovascular events after pregnancy. Arkansas’ rurality and health disparities
underscore the need for innovative strategies to address growing adverse health outcomes in the population.
The overall mission of the Arkansas Center for Women’s Health (ACWH) at the University of Arkansas for
Medical Sciences is to develop research and educational programs to enhance public health practice to reduce
risk for hypertension, hypertensive disorders of pregnancy and maternal mortality, among the state’s highest risk
women who have limited resources and health care access, with a long-term goal of eliminating chronic disease
health disparities. Through its networks and partnerships, the ACWH will conduct a scalability assessment to
rigorously assess the implementation outcomes (e.g., adoption, reach, acceptability, and facilitators), cost, and
scalability. With Arkansas’ current context of leadership in healthcare reform and healthcare delivery,
implementation of a statewide initiative (Healthy Active Arkansas), and a multidisciplinary team of investigators
with more than 30 years of experience in community-engaged, applied public health research and expertise in
women’s health, the ACWH is well-positioned to tackle this critically important public health issue among women
in rural areas of the state.

Public health relevance
PROJECT NARRATIVE Improving control of blood pressure among women with hypertensive disorders of pregnancy residing in rural, medically underserved counties, through a cost-effective, evidence-based public health intervention has the potential to reduce adverse maternal and fetal outcomes, including later onset of chronic hypertension and cardiovascular diseases, and maternal mortality. This implementation project developed with community partners, will assess a model for scaling up the intervention to other rural counties in the state.